Regulation of cardiac pacemaker cell cytoarchitecture

ABSTRACT:
Cardiac pacemaker cells (CPCs) rhythmically initiate the electrical impulses that stimulate heart contraction. CPC
dysfunction co-segregates with a broad variety of both cardiac and non-cardiac disease conditions and represents the
leading cause for the surgical implantation of artificial pacemakers. Moreover, CPC dysfunction is a leading cause of
sudden death among heart failure patients. Despite clinical burden of CPC dysfunction, very little is currently known
regarding the cellular pathologies that disrupt normal pacemaking. Indeed, we lack even a basic understanding of the
cellular and environmental conditions required for CPC homeostasis. Over the previous funding period, work conducted
within this R01 has uncovered a novel paradigm demonstrating that CPCs require low cellular strain to maintain the
cytoarchitectural features necessary for their function. Thus, the focus of this renewal application is to define the molecular
pathways that produce a microenvironmental niche around CPCs that functionally minimizes cellular strain. Importantly,
our preliminary data now demonstrate that CPCs express unique classes of paracrine factors which specifically activate
their local interstitial support cells. This activation drives the formation of a biomechanically compliant extracellular matrix
that surrounds and encapsulates CPCs (protecting them from contractile and hemodynamic forces present throughout
the rest of the heart). We have also identified that ectopically increasing cellular strain results in breakdown of CPC activity
and the loss of paracrine activation of their local interstitial cells. Collectively, these data have led to the hypothesis that a
mechano-paracrine positive feedback loop co-regulates the behavior of CPCs and their support cells patterning the local
tissue mechanics required for CPC activity. We will test this by defining the specific molecular pathways that integrate
mechanical feedback within CPC (Aim1), identifying the paracrine factors that maintain CPC-interstitial cell crosstalk
(Aim2), and determining how CPC-interstitial interactions changes under conditions of aging or pathological cardiac
remodeling (Aim3). Thus, successful execution of this proposal will create a novel and holistic model of CPC homeostasis
that accounts for the cooperative activity of multiple cell types within the sinoatrial node. We project these studies will
establish fundamental principles that define CPC developmental optimization, inform our overall understanding of CPC-
related disease progression, and instruct tissue engineering approaches designed to generate biological pacing systems
for therapeutic purposes.

Public health relevance
Project Narrative: Sinoatrial node dysfunction represents a significant clinical burden in the US and is the leading cause for surgical implantation of artificial pacemakers. This proposal seeks to define the underlying cellular interactions that maintain normal sinoatrial node function. Successful completion of these studies will uncover the homeostatic processes that support native cardiac pacemaking, identify how these processes become disrupted in disease, and provide critical insight for the design of next-generation of therapeutics for correcting human arrythmias.